BIOTRANSFORMATION OF FK506

FK506 is an immunosuppressant drug in Phase III clinical trial. The aim of this research is to investigate the pharmacokinetics of this drug, and the potential of drug/drug interactions, as well as the toxicity and activity of the metabolites of FK506.